Androgen Signaling in Prostatic Sonic Hedgehog Responsive Cells

PROJECT SUMMARY
The androgen-signaling pathway mediated through the androgen receptor is essential for prostate
embryonic development, prepubescent morphogenesis, and pubertal growth and regeneration. Mutation of the
Ar gene in testicular feminized mice results in the complete absence of prostate development. During
embryogenesis, the AR is initially detected in the urogenital sinus mesenchyme prior to the initiation of prostate
budding and morphogenesis, and its expression extends to the urogenital sinus epithelium after the initiation of
prostatic budding and branching morphogenesis. Early tissue recombination assays done more than 30 years
ago demonstrated that mesenchymal, rather than epithelial AR signaling plays a decisive role in inducing
development of the prostatic epithelium, providing the first scientific evidence for a stromal cell niche in
supporting prostate stem cell initiated prostate early development. Androgen signaling still remains essential
for prostatic postnatal morphogenesis, growth and regeneration. Prostatic regeneration through repeated
cycles of androgen withdrawal and replacement further demonstrates the essential role of androgen signaling
in prostate cell differentiation and growth. However, despite significant research effort in the past 30 years, the
underlying mechanisms by which androgens facilitate prostatic stem/progenitor cells through paracrine
interactions between prostatic epithelium and mesenchyme are largely unknown. Specifically, the cellular
properties of the AR-expressing mesenchymal cells that can convey androgen signaling to regulate prostatic
epithelial development and morphogenesis still remain unclear.
Sonic hedgehog signaling plays a critical role in prostate development, homeostasis, and regeneration
through mesenchymal–epithelial interactions. The Shh growth factors and its downstream effectors are
expressed in either prostatic epithelial or mesenchymal cells, respectively, during embryogenesis and
adulthood. Recently, using mouse genetic tools, we demonstrate for the first time that selective deletion of AR
in mesenchymal Gli1-expressing cells abolishes prostatic embryonic development and prostate formation, and
diminishes prostate pubertal growth and regeneration. In addition, results from our tissue recombination
assays showed that mesenchymal AR and Gli1 expressing cells act as cell niches in supporting prostate early
development and prostatic gland formation. These findings provide fresh insight into the cellular identity of the
stromal cell niche in supporting prostate stem/progenitor function in the prostate, and implicate a new
regulatory mechanism for stromal androgen and Shh signaling in regulating prostatic cell fate, growth, and
renewal. Based on these new and significant findings, we propose a series of experiments to test our central
hypothesis: stromal androgen signaling in Shh-responsive cells acts as a stem cell niche and plays an
essential role for prostate early development, prepubescent morphogenesis, and pubertal growth and
regeneration.

Public health relevance
PROJECT NARRATIVE Three specific aims are proposed in this R01 application to investigate the important but long-standing question regarding how stromal androgen signaling controls prostatic epithelial cell differentiation, growth, and regeneration. Data generated from this study will greatly enhance our current knowledge in the fields of androgen signaling, stem cell niches, and prostate development.